Decoding cis-regulatory element activity through deep learning frameworks

Project Summary
Gene expression is tightly regulated by cis-regulatory elements (CREs), which interact with transcription
factors and other regulatory proteins to control when and where genes are expressed in different cell types.
While millions of CREs have been annotated across the human genome, key questions remain about how
these elements work together, how their function varies across cell types, and how they influence alternative
isoform usage. Addressing these gaps is essential to understanding the complexity of gene regulation and its
role in human health and disease.
This project seeks to answer three critical questions: (1) How do cCREs interact in a combinatorial manner to
regulate gene transcription? (2) How do cCREs exhibit context-dependent activity in different cell types? (3)
How do cCREs contribute to the regulation of transcript isoform usage, beyond simply controlling gene
expression? We will answer these questions by leveraging deep learning models, such as convolutional neural
networks (CNNs), to analyze large-scale genomic and epigenomic datasets. Deep learning will allow us to
uncover non-linear patterns of cCRE interactions and predict their regulatory effects across different cellular
contexts.
To validate our computational predictions, we will employ high-throughput experimental techniques such as
STARR-seq and CRISPR-based perturbation assays. These experiments will assess the regulatory activity of
cCREs in their native chromatin environments, allowing for direct testing of combinatorial effects,
context-dependent functions, and their impact on transcript isoform expression. Ultimately, this research will
provide new insights into the regulatory mechanisms underlying gene expression, with implications for
understanding complex diseases and developing targeted therapeutic strategies.

Public health relevance
Project Narrative This project aims to use deep learning models to understand how specific DNA sequences regulate gene expression in different cell types and contexts. By studying the functions and interactions of regulatory elements, this research will provide new insights into the mechanisms that control gene activity, which is essential for understanding diseases.